National Biomedical Resource for Electron-Spin Resonance Spectroscopy (ACERT)

Project Summary: This is an R24 proposal to establish a Regional and National Resource in modern Electron-
Spin Resonance (ESR) Technology for use by the biomedical community. This resource will build upon 20 years
of a very successful National Biomedical Center: ACERT (funded by an NIH P41 grant), in which the new ESR
technologies that were developed, driven by biomedical collaborators, were then provided to extensive
collaborators and service projects. In its new configuration as an R24 resource, it will focus on user services and
collaborations utilizing the already established extensive and unique technologies that have already been
developed. We have a well- established administration and operations scheme for this objective. Through
outreach efforts we plan to significantly expand the user base both nationally and internationally. We will be
providing extensive educational and training capabilities for the expanded user base. This will include a series of
workshops, on-line resources, in house training and visits to other labs. The outreach will include tutorial papers
in key journals, virtual meetings with the International ESR Society, video lectures on YouTube, and
advertisements in leading Journals and Newsletters. The ESR resources we provide are in many ways unique in
the world. In addition to our commercial spectrometers for cw and pulse ESR covering the frequency range of 9
to 35 GHz, we have extensive and unique custom-home built spectrometers covering the range of frequencies 9
to 240 GHz. These spectrometers are dedicated to a full range of ESR methods utilized by the biomedical
community, especially including techniques for conducting pulse dipolar ESR (PDS), which provides distances
between labeled protein and RNA sites from which protein tertiary structure may be inferred. It is applicable to
protein complexes in their natural states. ACERT has developed methods that both significantly increase the
sensitivity to low sub- micromolar protein concentrations and very small samples, and they greatly increase the
throughput, enabling a greater rate of processing of the many samples studied in PDS. While PDS supplies
protein structures, the additional techniques of multi-frequency ESR and pulsed 2D-ESR at ambient
temperatures supply details of protein dynamics, important in learning about structure/function; this includes
the unique ability to study in real time nanosecond to microsecond dynamics, which will address such issues as
domain motions in proteins. Our innovative software enables the fitting of the complex 1- and 2-D spectra to
extract the details of the complex protein motions, and our recent developments of signal processing software
have led to unique packages for greatly increasing the signal-to-noise of weak ESR signals while providing great
fidelity, as well as accurately transforming the results of PDS experiments into (complex) distance distributions.
These software methods will also enhance the throughput of the Resource.

Public health relevance
Project Narrative: This Regional and National Resource will provide cutting-edge electron-spin resonance spectroscopy capabilities for biomedical researchers engaged in NIH-sponsored projects aimed at understanding and combatting diseases and ailments (e.g., AIDS, allergies and inflammations, ALS, Alzheimer's, bacterial infection, cancer, cardiac disease, depressive disorders and schizophrenia, Ebola virus infections, eye disorders, infertility, neurological disorders, Parkinson's, and SARS-Cov-2). Through service and collaboration, both experimental and computational techniques will reveal disease mechanism through the study of macromolecular structure, dynamics and function.